Metabolome-wide anaysis for the risk-stratification of sudden cardiac death

DESCRIPTION (provided by applicant): Sudden cardiac death (ASD) is a major public health problem affecting over 300,000 individuals in the United States each year. Over 5 million individuals in United States who have advanced left ventricular (LV) dysfunction, usually secondary to myocardial infarction or non-ischemic cardiomyopathy, are considered to be a high-risk of SCD. The current guidelines recommend a prophylactic placement of an implantable cardioverter defibrillator (ICD) in patients with a LV ejection fraction (LVEF) of <35%. The procedure itself is not curative, is associated with high costs, and is not free from short- and long-term adverse effects. Moreover, this preventive strategy, based on LVEF alone, results in 10 times more ICDs implanted than required to save a life, and in general reflects the limited understanding of the biologic pathways predisposing to ASD. In considering these risks, the impaired quality of life, and the increasing burden on the exiting resources due these expensive devices, there is a clear need for the development better risk-stratification techniques. As the currently known risk-factors for SCD are neither sensitive nor specific, this proposal is aimed at developing a novel biomarker panel that will help identify individuals who are at an increased risk of SCD, and thus the ideal candidates for ICD implantation. This proposal is an ancillary study within two of the largest, well-established, RO1-funded, and nationally representative cohort studies of patients undergoing ICD implantation - the PRospective Observational Study of the ICD in SCD (PROSE-ICD, n=1,200) and the Genetic Risk Assessment of Defibrillator Events (GRADE, n=2,000) studies. Both parent cohorts have remarkably similar enrollment criteria, patient characteristics, and availability of biologic material necessary for this study. The ancillary study will leverage the strengths of unbiased metabolome-wide scans, which include thousands of final downstream products of gene transcription, enzyme activity and metabolic products of extraneously administered substances, in order to identify a metabolomic fingerprint associated with at an increased risk of SCD. While the large sample size and the availability of independent discovery and validation cohorts will eliminate false positive associations, the availability of stringently phenotyped parent cohort will provide novel insights into the biologic and mechanistic pathways by which these metabolites may predispose to SCD. As the metabolome is the most proximal 'snapshot', the identification of the proposed metabolite panel will be a significant addition to the currently used risk-prediction algorithms for SCD and perfectly complement the overall specific aims of the parent cohorts. The results of this ancillary study will have direct implication over 5 million individuals who are considered ICD eligible and some findings may be applicable to the general population where majority of SCDs occur.

Public health relevance
PUBLIC HEALTH RELEVANCE: Under current guidelines, over five million individuals in the United States with advanced heart disease are considered to be at a high risk of dying suddenly, and therefore eligible for the implantation of cardioverter defibrillators for prevention of arrhythmic sudden cardiac death. The current risk-stratification algorithm, based on heart function alone, results in the implantation of 10 or more of these devices for each life saved. This proposal aims at developing a novel biomarker panel based on unbiased scans of over 2,000 downstream metabolic products of genes, enzyme activity, and extraneously administered substance (collectively known as the human metabolome), in order to identify individuals who will truly benefit from these expensive devices. NARRATIVE Under current guidelines, over five million individuals in the United States with advanced heart disease are considered to be at a high risk of dying suddenly, and therefore eligible for the implantation of cardioverter defibrillators for prevention of arrhythmic sudden cardiac death. The current risk-stratification algorithm, based on heart function alone, results in the implantation of 10 or more of these devices for each life saved. This proposal aims at developing a novel biomarker panel based on unbiased scans of over 2,000 downstream metabolic products of genes, enzyme activity, and extraneously administered substance (collectively known as the human metabolome), in order to identify individuals who will truly benefit from these expensive devices. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS Sudden cardiac death (SCD) is a major public health problem with an annual incidence of over 300,000 in the United States alone. The majority of the SCD is arrhythmic in nature and the use of implantable cardioverter defibrillator (ICD) in 'high-risk' individuals has been the major advance in the primary prevention strategy for SCD in the past decade. Under the current guidelines, over 5 million people in the United States with advanced left ventricular dysfunction qualify for ICD implantation for primary prevention of SCD. This strategy based on ejection fraction alone is neither sensitive nor specific, and in general, requires implantation of more than 10 ICDs for every device that saves a life. Moreover, the high costs and altered quality of life associated with ICD implantation makes this approach virtually impossible at a public health level, and there is a pressing need for better risk stratification strategies. This has remained challenging due the complex biology of SCD, which includes genetic, environmental, pharmacologic, and dietary determinants. There is a growing body of evidence suggesting that the metabolic milieu of cardiomyocytes, both normal and injured, contributes to the generation of arrhythmias associated with SCD. However, there are no systematic and comprehensive clinical studies evaluating the influence of the metabolic profile on SCD risk in patients. As these metabolites can be easily and accurately measured in peripheral blood, the objective of this proposal is to develop a biomarker panel based on metabolomic profiling of serum in order to identify patients who are a high-risk for SCD. High-throughput metabolomics allows the simultaneous quantitative assessment of thousands of small-molecule metabolites found in serum of patients in an unbiased way. The human metabolome represents a collection of the final downstream products of gene transcription, enzyme activity as well as the metabolic products extraneously administered substances, thus reflecting the closest 'snapshot' of cellular processes both in normal physiology and disease. We hypothesize that: 1. Baseline serum metabolomic profiles of patients undergoing ICD implantation for primary prevention of SCD can predict future SCD risk independent of established risk-factors for SCD. 2. Establishing a biomarker panel in a prospective cohort of high-risk patients based on simultaneous assessment of thousands of metabolites, and its subsequent validation in an independent cohort will provide an unbiased assessment of the association of metabolomic patterns with the risk of SCD. 3. Validated metabolomic profiles associated with the risk of SCD will also explain the variability in the electrocardiographic (ECG) markers of increased SCD risk and other intermediate phenotypes of SCD. 4. Variability in the risk of SCD among these patients can be explained by temporal changes in the levels of metabolites that are associated with SCD risk. We propose an ancillary study using two of the largest NHLBI-funded prospective cohorts of patients undergoing ICD implantation. PRospective Observational Study of ICD (PROSE-ICD) is a prospective cohort of 1,200 (>1,125 currently enrolled) patients with post-myocardial infarction and non-ischemic cardiomyopathy (ejection fraction <35%) undergoing primary prevention ICD implantation (RO1 HL091062). Genetic Risk Assessment of Defibrillator Events (GRADE) study is a prospective cohort of 2,000 (>1,700 currently enrolled) patients undergoing ICD implantation (RO1 HL077398). The enrollment criteria for both cohort studies are remarkably similar. A surrogate of SCD referred to as arrhythmic sudden death (ASD) defined as adjudicated ICD shocks for ventricular tachycardia (VT) or fibrillation (VF), and deaths due to VT/VF not corrected by the ICD is well-characterized in the both studies. Stored electrograms in the ICD facilitate the accurate adjudication of potentially lethal VT/VF. The specific aims of this proposal are: Aim 1: To define the baseline metabolomic profile associated with an increased risk of ASD. This will be carried out in two phases: a. Discovery phase: This will be carried out using the PROSE-ICD cohort. Over 2,500 small molecule metabolites will be simultaneously quantified using liquid chromatography - mass spectrometry. To optimize resources and restrict cost, we will employ a case-cohort approach. Cases will be all incident cases of adjudicated ASD (expected n=362) occurring since study inception through December 31, 2013, an average follow-up of ~8 years. Controls (n=400) will be a random sample from PROSE-ICD at baseline. b. Validation phase: This will also be carried out using the case-cohort design among 600 GRADE participants who have received an ICD for primary prevention of SCD. Definition of cases and controls will be identical to that used in the discovery phase. The top 10% of the 'hits' identified in the discovery phase will be measured in this cohort. The phase will ensure the elimination of false-positive associations arising from simultaneous measurement of thousands of exposures in the discovery phase. Aim 2: To determine whether these metabolites are associated with the intermediate phenotypes of ASD. The validated panel of metabolites will be measured in the entire PROSE-ICD cohort. The association between these metabolites and the established SCD intermediates will be assessed. These intermediates are well characterized under auspices of the grant RO1 HL091062 and include signal averaged electrocardiograms (a measure of conduction), HR variability (a measure of autonomic tone), QT variability (a measure of repolarization), and VT inducibility with programmed electrical stimulation. Aim 3: To examine the incremental value of this metabolite panel in the existing risk-stratification algorithms. The validated panel of metabolites will be combined with traditional risk-factors as well as novel markers identified in PROSE-ICD (also as the main specific aims of RO1 HL091062) to develop optimal risk prediction equations for ASD risk. The incremental value of metabolites assessment will be assessed using advanced statistical methods. Aim 4: To assess the utility of serial measurement of metabolites in prediction of ASD risk. The validated panel of metabolites will be measured in serially collected blood in a subset of 100 PROSE-ICD patients (50 cases and 50 controls) to assess the effect of temporal variability of these metabolites on ASD risk. The unique strengths of this proposal include the availability of independent discovery- and validation- study samples, extensive and stringent phenotyping for SCD risks, the availability of uniformly collected and stored blood samples for analysis, and state-of-the-art tools for metabolomic profiling. The results of this investigation will help develop a tool for risk-stratification for SCD, which will add significantly to the existing algorithms that are largely based on ejection fraction alone. The current preventative approach for SCD, based on the use of ICD, is a palliative approach and does not treat the underlying disease. This investigation will provide novel insights into the biologic pathways leading to SCD, which will in turn aid the development of newer therapeutic measures for reducing SCD risk.